Circadian Clock and Dietary Restriction

Diet is an important factor influencing health and disease. Calorie restriction (CR) improves metabolism,
delays aging, and reduces the incidence of many age-associated diseases such as cancer, diabetes, and
cardiometabolic. mTOR signaling pathway plays a central role in the control of aging and CR mechanisms. We
will expand the current model on the regulation of mTOR signaling by diet in vivo, by exploring crosstalk
between diet and circadian rhythms in metabolic signaling and gene expression. We will test the hypothesis
that CR reprograms the expression of mTOR regulatory network through circadian clock-dependent
mechanisms. The reprogramming changes the balance in the mTOR network and impacts the response of
mTOR signaling to growth factors and nutrients challenges. Reprogramming of circadian rhythms in mTOR
signaling is important for metabolic adaptation to CR. In vivo and ex vivo approaches and wild-type and
circadian clock mutant mice will be used to compare the impact of CR with the impact of AL and fasting on
mTOR signaling. The study will help to dissect contributions of fasting and reduced calorie intake to CR
improved metabolism and longevity.

Public health relevance
Project Narrative. This project investigates connection between circadian clocks and mTOR signaling rhythms in calorie restriction. The circadian clock, mTOR pathway and calorie restriction are major regulators of metabolism and aging. The obtained data will help to develop a strategy for the treatment and prevention of age-associated diseases.